Validation of the GMFC-MLD

Description of the Research Project for the Supplementee
The proposed work is distinct from, but within the scope of the existing GLIA-CTN funded-projects. This
subproject focuses on metachromatic leukodystrophy (MLD), which is included broadly for data collection in
Project 1. There is not an MLD-specific project as part of the GLIA-CTN. During the proposed work, Ms. Mutua
will learn the steps on how to design and implement a rigorous natural history study from data base creation to
development of standard operating procedures to data collection to statistical analysis. In her first year as a
coordinator in the GLIA-CTN, Ms. Mutua was responsible for document preparation and data base
management for the MLD natural history project. This involved the creation of clinical trial-style documentation,
including case report forms and binders, for our natural history participants. She has worked closely with
members of our data management core regarding data curation. She has performed statistical analysis on the
related pilot data for this project with the close supervision of our statistics team. As such, she is deeply
knowledgeable about implementation of a rigorous natural history study. She has studied statistics formally in
college as well. The proposed work is well within the skills she has developed in the past year. This project
supported independence and will nurture her passion for translational medicine and neuroscience.

Public health relevance
Summary of the Funded Grant or Project The parent RDCRN program is the Global Leukodystrophy Initiative Clinical Trial Network (GLIA-CTN). This program is in its first cycle (entering Y5) and is a collaboration of 8 US leukodystrophy centers. The primary aims focus on harmonization and curation of leukodystrophy natural history data using standard functional and patient reported outcome measures as well as electronic health records. The parent program supports the collection of data related to metachromatic leukodystrophy but does not include targeted research in this condition.